Development and testing of a smartphone-delivered climate adaptation and IPV and related stress intervention for residents of informal settlements in Kenya using ecological momentary approaches

PROJECT SUMMARY
Climate change (CC) and related weather events are expected to impact intimate partner violence (IPV). Women
in informal settlements in lower- and middle-income countries (LMICs) are more likely to be experiencing IPV,
less likely to have access to services, and more vulnerable to the effects of CC and related extreme weather
events (EWEs). Despite the potential impacts of CC on IPV, strategies to adapt to CC in these settlements, i.e.,
reducing the consequences of mounting climate challenges, have overlooked violence-related outcomes. In
particular, there is a paucity of interventions to help residents of informal settlements experiencing IPV to adapt
to or minimize the impact of CC on their safety and well-being. The purpose of this exploratory/developmental
R21/R33 study is to develop and test the preliminary efficacy of a smartphone-delivered climate adaptation safety
and harm reduction intervention for women experiencing IPV in informal settlements in Kenya using ecological
momentary intervention (EMI) and ecological momentary assessment (EMA). We will achieve this goal through
the following aims: R21: Aim 1 is to develop and pilot a smartphone-based application to collect real-time EMA
information about IPV experiences, emotional stress, IPV self-efficacy, receipt of IPV-related social support and
services, safety, climate-related comfort, social and environmental context, and current behaviors from 320 IPV
survivors in informal settlements. Participants will complete EMAs thrice daily for a two-week baseline period
and for two-weeks following three common types of EWEs (heatwave, cold spell, heavy rainfall). R21: Aim 2: is
to use AIM 1 data to explore important, but understudied associations between climate and IPV. R33: Aim 1 is
to adapt an evidence-based Wings of hope intervention (WINGS) for integration into the EMA application
developed in the R21 study. R33: Aim 2 is to test the feasibility and preliminary efficacy of the event-triggered
WINGS-based EMI adapted in R33: Aim 1 through a randomized control trial (RCT). Participants retained from
the R21 phase (n=272), will be randomized to receive either a single-session, mobile version of WINGS (n=136)
or the event-triggered, WINGS-based EMI adapted in R33: Aim 1 (n=136). For nine months, participants
assigned to the event-triggered EMI will be prompted to participate in daily EMIs for two-weeks following EWEs.
They will also be prompted to complete daily EMAs during these two-week periods. All participants, regardless
of assignment, will be asked to complete digital assessments at baseline, immediately following receipt of the
single-session of WINGS, and at 3-, 6-, and 12-months. The goals of this study are: to provide women with a
low-cost, accessible, smartphone-based tool that empowers them to develop, utilize, and revise personal safety
and harm reduction strategies that are specifically responsive to climate-related IPV and to provide survivors
with interventions in real-time. Findings could support a low-cost, sustainable, and easily adaptable climate
adaptation and IPV response application and implementation model for informal settlements or other under-
resourced settings, globally.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to develop, pilot, and test the feasibility and preliminary efficacy of a smartphone- delivered climate adaptation safety and harm reduction intervention for women experiencing intimate partner violence (IPV) in informal settlements in Kenya using ecological momentary approaches. The project will: (1) develop, test, and modify a smartphone-based EMA application designed to collect information on female residents’ IPV experiences, emotional stress, IPV self-efficacy, receipt of IPV-related social support and services, safety, climate-related comfort, social and environmental context, and current behaviors in informal settlements (R21: Phase 1); (2) pilot test the EMA application among 320 women living in two large informal settlements in Nairobi, Kenya and use the data collected to explore important, but understudied associations between climate and IPV in informal settlements (R21: Phase 2); (3) adapt an evidence-based Wings of hope (WINGS) intervention for integration into the smartphone-based EMA application developed in the R21 phase (R33: Phase 1); and (4) test the feasibility and preliminary efficacy of the adapted WINGS-based ecological momentary intervention (EMI) through a randomized control trial (RCT) (R33: Phase 2). The goals of this study are: to provide women with a low-cost, accessible, smartphone-based tool that empowers them to develop, utilize, and revise personal safety and harm reduction strategies that are specifically responsive to climate- related IPV and, in doing so, to provide survivors with interventions in real-time.